Proteogenomic Predictors of Recurrence in Non-small Cell Lung Cancer

PROJECT SUMMARY/ABSTARCT
Lung cancer is a leading cause of cancer-related death globally. Nearly a third of patients with non-small cell
lung cancer (NSCLC) present with potentially resectable early-stage NSCLC. Despite complete resection,
approximately 50% of patients with stage II and III NSCLC recur and die from metastatic NSCLC. There are no
reliable biomarkers to predict poor outcomes in early-stage NSCLC. Molecularly targeted therapies and
immune checkpoint blockade targeting programmed death-1 (PD-1) or programmed death ligand-1 (PD-L1)
have significantly improved the outcomes of patients with metastatic NSCLC, and these agents are now
undergoing clinical trials in early-stage lung cancer following standard therapy. The National Cancer Institute
(NCI) has launched an ambitious multicenter study, the Adjuvant Lung Cancer Enrichment Marker
Identification and Sequencing (ALCHEMIST), to screen nearly 8000 patients with completely resected NSCLC
to identify those with activating mutations in the epidermal growth factor receptor (EGFR) tyrosine kinase (TK)
and rearrangements in anaplastic lymphoma kinase (ALK) to investigate the role of erlotinib and crizotinib,
respectively. Those with tumors lacking EGFR mutation or ALK rearrangement were offered participation in a
randomized trial comparing nivolumab, an inhibitor of PD-1 to observation. The ALCHEMIST Genomics
Working Group is planning to study the tumor whole genomes, exomes, and transcriptomes from nearly 2000
patients who did not participate in the intervention trials (ALCHEMIST Screening Study) and all those enrolled
in the three ALCHEMIST therapeutic trials. This suite of trials with data generated using genomic analyses
provides a unique opportunity to explore the role of the cancer proteome in predicting outcomes in patients
with resected NSCLC. We propose a Proteogenomic Translational Research Center (PTRC) to study the
proteogenomic alterations in resected early-stage NSCLC co-led by the Washington University School of
Medicine (WUSM) and the Broad Institute along with investigators affiliated with the NCI-funded National
Clinical Trials Network (NCTN) supporting the ALCHEMIST suite of clinical trials. Our overarching objective is
to apply mass spectrometry-based global and targeted proteomic analyses to patient-derived resected tumor
material to improve upon the predictive biomarkers using somatic cancer genome and transcriptome and
clinical characteristics. These discoveries will be translated into targeted assays to predict recurrence
following therapy. Since the ALCHEMIST Crizotinib study is still ongoing and has enrolled relatively fewer
patients compared to other studies, we will not include those samples in this proposal. The three aims of this
project are to develop prognostic assessment tools to predict relapse in patients with resected NSCLC treated
with standard platinum doublet chemotherapy (aim 1), standard platinum doublet chemotherapy and nivolumab
(aim 2), and standard platinum doublet chemotherapy and erlotinib (aim 3) using proteogenomics.

Public health relevance
PROJECT NARRATIVE The proposed project aims to develop predictive biomarkers for relapse following surgery and postoperative systemic therapy in early-stage non-small-cell lung cancer using mass spectrometry-based global and targeted proteogenomic analyses of human lung cancer specimens from clinical trials.